2022 Bones and Teeth Gordon Research Conference and Seminar

Summary/Abstract
The skeleton is an organ composed of many tissues and with a variety of fundamental and vital functions.
In the last few years, it has become increasingly clear that the metabolic pathways and local environments
have a crucial role in the biology of the skeleton. Those new developments are opening exciting avenues
for research. They may also lead to novel treatments of devastating conditions such as osteoporosis,
osteopetrosis, bone cancer, and genetic disorders of the skeleton, as well as systemic pathologies,
including the dysregulation of bioenergetic metabolism. The theme of our conference is “Metabolism and
local environments in development, disease and regeneration of the skeleton”. Significant progress in the
understanding of local communication among cells that form bone and maintain its integrity during the
lifespan of the organism will be presented. Likewise, the interactions of bone cells with the other tissues
constituting the skeleton, namely blood vessels, hematopoietic marrow, bone marrow fat, bone marrow
stroma, and tendons will be examined. Lastly, the molecular and cellular mechanisms within the skeleton
that integrate local interactions, bioenergetics metabolism and biomechanical forces will be discussed.
The overall goal of the conference is to encourage the pursuit of new research directions and novel
therapeutic approaches, as well as foster highly productive collaborations among top laboratories in the
field. Based on the successful Gordon Research Seminar (GRS) that preceded the B&T GRCs in previous
years, the GRC organization has approved a GRS associated with the 2022 B&T GRC. The 2022 B&T
GRS, organized by Shauni Loopmans and Claire Arata, will be called "From bench-to-bedside:
understanding the skeleton for developing therapies" and will focus more on the importance of
understanding metabolic requirements and environmental factors in the bone for its translation toward
therapies. GRS will feature a mentorship program that provides guidance to early-stage scientists on
career development. This year, the mentorship component will be called “A roadmap to being successful
in academia”. The organizers will select talks from submitted abstracts, and all attendees are encouraged
to present posters and stay for the subsequent GRC. Based on the previous experiences, young scientists
excited by GRS participation remain highly engaged at the GRC.

Public health relevance
Project Narrative The skeleton is an organ with numerous vital functions. The 2022 Bones and Teeth Gordon Research Conference and Seminar will discuss major new discoveries regarding the skeleton and its functions. Those new and exciting discoveries may lead to novel treatments of devastating diseases including osteoporosis, bone cancer, genetic disorders of the skeleton and skeletal problems associated to diabetes.